Investigating the Mechanisms of Brain-Heart Communication Under Stress

Project Summary/Abstract
Stress-induced disruptions in brain and heart communication can perturb the balance between
sympathetic and parasympathetic responses, potentially causing health consequences across
multiple domains. Our laboratory has focused on understanding the mechanisms of organ-organ
communications under stress via two pathways: vagus nerve-to-brain and brain-to-heart. The
vagus-to-brain communication involves the nodose ganglion, transmitting sensory interoceptive
information such as heart rate to the nucleus of the solitary tract (NTS), the brain's visceral center.
The parasympathetic regulation of the cardiovascular system occurs through the nucleus
ambiguus (NAmb) brain region, a crucial brain-to-heart communication circuit. The Principal
Investigator (PI) has made significant strides in investigating brain and heart interactions through
pilot studies. Our preliminary findings show that ethologically relevant stressors negatively affect
these two parasympathetic regulations, leading to disruptions in behavior, cardiorespiratory,
immune, and other functions. We have further discovered the role of the neuropeptide pituitary
adenylate cyclase polypeptide (PACAP) and its receptor PAC1 in modulating the nodose ganglion
of the vagus nerve to NTS and the NAmb to heart circuits, shedding light on cellular mechanisms
of interoceptive signaling during stress. The Maximizing Investigators' Research Award (MIRA)
R35 project will elucidate the intricate neural mechanisms connecting the brain and heart during
stress, focusing on two communication mechanisms: bottom-up (nodose ganglion to NTS) and
top-down (NAmb to heart). The current project fits well with NIGMS's focus on multiorgan
physiology under stress in the Division of Pharmacology, Physiology, and Biological Chemistry.
In this proposal, we will explore the impact of the nodosePACAP to NTS and NAmbPACAP to heart on
behavior, cardiorespiratory, and cardiovascular functions. The MIRA for Early-Stage Investigators
(ESI) allows simultaneously investigating the brain and heart communication in stress through
complementary top-down and bottom-up pathway analyses. In the next five years, our research
will uncover stress-related organ-organ communication mechanisms, focusing on neuropeptide
pathways and understanding the intricate processing of bodily signals. The project's overarching
vision is to rigorously investigate stress-related effects on brain-body communication, addressing
a critical gap in stress biology research. While rooted in basic science in mice, the research has
broader implications for practical applications to general medicine.

Public health relevance
PROJECT NARRATIVE This proposal investigates organ-organ communication mechanisms, focusing on interactions between the brain and the heart in stressed mice. Our goal is to unravel how stress interferes with brain-to-heart and heart-to-brain communication, with implications for mental health, immune functions, metabolism, and others. To achieve this, we will conduct a comprehensive analysis encompassing molecular genetics, behaviors, cellular dynamics, and cardiorespiratory aspects of specific neural circuits connecting the brain and heart.